The role of extracellular matrix in axon routing

Project Summary/Abstract
Vision, in general, and stereopsis, in particular, depends on the selective decussation of retinal ganglion cell
axons and their termination in an orderly topographic manner. Axonal decussation is directed by the radial glia
and midline line neurons at the optic chiasm. The radial glia and midline neurons attach to the pial basement
membrane (PBM), a cell adherent, highly organized extracellular matrix sheet that forms the basal surface of the
brain including the chiasm. A key component of the PBM are laminins. In other brain regions laminins containing
the 2 subunit (2 laminins) provide environmental cues that control tissue and cellular organization including
polarity, proliferation, and differentiation. We hypothesize that 2 laminins in the PBM of the chiasm function to
polarize the radial glia and midline neurons. This polarization, in turn, regulates the spatial organization of
guidance cues thereby regulating axon decussation. Consistent with this hypothesis, we found that loss of 2
laminins from the PBM decreased axonal decussation resulting in an increased ipsilateral projection. We will
critically test this hypothesis in three aims. In Aim 1 we will determine the role of 2 laminins in the control of
axonal guidance cue expression during the early, peak, and late phases of axon growth. In Aim 2, we will
determine which laminin receptors are required for the polarity of radial glial cells and axon decussation using a
combination of in vivo and in vitro approaches. Our in vivo experiments will employ cell specific deletion of laminin
receptors, while our in vitro experiments will employ a technically innovative organotypic approach using function
blocking techniques. In Aim 3, we will determine how 2 laminins control the radial glia and midline neuron cell
polarity using sparse labeling of the cells and high-resolution microscopy. The experiments proposed here will
define the role of the β2 laminins during optic chiasm and tract formation. The findings from this work will pave
the way to exploit cell-matrix interactions for the development of rational strategies to promote the guided growth
and decussation of regenerating retinal ganglion cell axons.

Public health relevance
Project Narrative The selective routing of retinal ganglion cell (RGC) axons to the correct side of the brain by the cells of the optic chiasm is required for normal vision. Here we investigate how β2 laminins, an essential component of the extracellular matrix sheet surrounding the brain, controls the organization of the cells in the optic chiasm and thereby the selective routing of RGC axons. The findings from this project will lead to new insights into the regulation of selective axon routing and the development of rational strategies for RGC axon regeneration and brain target selection.